Coordinating Unit for the National Centers for Metabolic Phenotyping in Live Models of Obesity and Diabetes (MPMOD)

The National Centers for Metabolic Phenotyping in Live Models of Obesity and Diabetes (MPMOD) will be a
multi-center initiative funded by the NIH to provide state-of-the-art technologies to investigators for a fee, with
their services including characterization of mouse metabolism, blood composition (including hormones), energy
balance, eating and exercise, organ function and morphology, and physiology. The MPMOD Coordinating Unit
(CU) will be responsible for supporting MPMOD by creating/maintaining the website, administratively organize
the meetings and workshops sponsored by the MPMOD to engage the greater mouse metabolism scientific
community as well as develop the Vibrant Program to establish a P&F funding program and outreach to
underserved researchers and institutions. In addition, the CU will be responsible for managing and organizing
the activities of the MPMOD Center sites to provide quality phenotyping services to the scientific community.
The CU is responsible for creating and maintaining the administrative, scientific and informatics infrastructure
necessary to organize and facilitate their operations. The goal of this proposal is to provide that infrastructure.
Over the last 15 years, our group has successfully managed and created the infrastructure as the CU for the
NIDDK Mouse Metabolic Phenotyping Centers (MMPC). The mission of the MMPC was similar to MPMOD,
allowing us to build upon the success of the established MMPC CU infrastructure to provide MPMOD with a
robust and comprehensive service oriented solution that has been tested over time and supports the unique
aspects of this consortium.

Public health relevance
The National Institute of Diabetes and Digestive and Kidney Diseases (NIDDK) is providing funds to establish the coordinating unit (CU) for the National Centers for Metabolic Phenotyping in Live Models of Obesity and Diabetes (MPMOD) program. The CU will coordinate the interactions of the MPMOD Phenotyping Centers, provide financial management for the MPMOD Vibrant Program, interact with the Executive Steering Committee and External Scientific Panel as well as provide a national web portal for MPMOD in order to disseminate information and provide an organizational infrastructure for the program. This application will provide the infrastructure for the CU for MPMOD.